Role of clonal somatic mutations in microglia and Alzheimer’s disease

Project Summary/Abstract
Alzheimer’s disease (AD) and other neurodegenerative diseases are characterized by age-related
onset and progressive neuronal loss. Neuroinflammation mediated by disease-associated microglia is
increasingly implicated in AD pathogenesis. As the primary immune cells in the brain, abnormally reactive
microglia have been recently found to create a neuroinflammatory environment that results in neuronal death,
yet the mechanisms by which age and genetic factors interact remain largely unknown. Somatic mutations
accumulate in various cell types during the development and aging process of the human body. Clonal
expansion, driven by somatic mutations in genes regulating cell proliferation, is associated with an increased
risk of cancer with age, but has only recently been linked to a growing list of non-cancer neurological diseases.
Notably, somatic BRAF mutation in the microglial lineage has been implicated in histiocytosis-associated
neurodegenerative conditions. Our preliminary results from three AD cohorts and with three sequencing
technologies consistently show an excess of clonal somatic mutations in AD brains, particularly in proliferation-
related genes of microglia.
This new study aims to examine if the accumulation of somatic mutation contributes to an age-related
increase in AD risk by driving clonal expansion of microglia, which subsequently induces neuroinflammation
and neuronal loss in AD brains. The first Aim of the study is to identify somatic mutations by re-analysis of the
existing bulk RNA-seq datasets from large AD cohorts, and compare the transcriptome-wide burden and
distribution of somatic mutation between different brain regions of AD patients and matched controls. In the
second Aim of the study, molecule-barcoded ultra-deep panel sequencing will be applied to screen for somatic
mutations more sensitively among genes that regulate cell cycle and proliferation in AD and control brains; we
will further use amplicon sequencing to quantify the mutant allele fraction across different cell types sorted from
AD brains, to verify if these somatic mutations are specifically carried by microglia. The third Aim of the study
will focus on the functional impact of proliferation-related somatic mutations in AD microglia, by using both an
in silico method based on AD single-nucleus RNA-seq data and an in vitro method based on a human stem-
cell differentiated microglia model. Our proposed study will shed new light on the contribution of somatic
mutation to increased AD risk, and highlight the clonal expansion of microglia driven by somatic mutations in
proliferation-related genes as a potential mechanism involved in AD pathogenesis.

Public health relevance
Project Narrative Alzheimer’s disease (AD) and other neurodegenerative diseases are characterized by age-associated neuronal loss, which involves neuroinflammation induced by reactive microglia. Our preliminary analyses from three AD cohorts and with three sequencing technologies consistently revealed an excess of clonal somatic mutations in AD brains, particularly in proliferation-related genes of microglia. We plan to test our hypothesis that the accumulation of somatic mutation contributes to an age-related increase in AD risk by driving the clonal expansion of microglia, which subsequently induces neuroinflammation and neuronal loss in AD brains.